Pediatric Global Health Subspecialty Fellowship

PROJECT SUMMARY / ABSTRACT
To optimally support global child health and development, research needs to be designed to account for the
scale of disease burden and child mortality that occurs worldwide. A robust global pediatric health research
strategy depends upon new investigators with the technical expertise required to translate basic science to
population health and wellness. Although the US leads the world in biomedical research, none of the 39 NIH
funded global health institutional training grants are focused solely on improving health for children in
low- and middle-income countries, and none are from NICHD. General pediatric global health fellowships limit
career opportunities for clinician scientists, further restricting researchers to high income health systems.
We will capitalize on the significant teaching and research resources that exist across Stanford University to
develop the next generation of pediatric subspecialty global health researchers. We propose a dual
fellowship training approach which will encompass both the trainee’s pediatric subspecialty as well as
a focus on global health approaches to subspecialty research. Resources such as the co-located seven
schools which make up teaching and research at Stanford University, as well as the surrounding Silicon
Valley, offers a unique entrepreneurial and technologically innovative environment, will serve as the hub of an
interdisciplinary environment to build a cross-cutting research program addressing the needs of children in low-
and middle-income countries. The program PI has directed T32 programs for over a decade and is the
School of Medicine Senior Associate Dean for Faculty Development and Diversity, so is well-positioned to
provide substantial mentorship and leadership resources for the trainees. Stanford has a group of highly
experienced and well-funded global child health researchers with substantial mentorship and clinical
experience who work across the spectrum of low- and middle-income countries. Finally, the proposal includes
a unique pediatric subspecialty global health curriculum that integrates with existing rigorous coursework
and a Master’s in Epidemiology program to provide the foundation for the proposed training program.
Two Stanford pediatric subspecialty fellows will be selected per year, beginning in their second year of
training. Trainees will: (1) complete a Master of Science in Epidemiology and Clinical Research; (2) receive
structured dual-mentorship by both subspecialty and global child health researchers; (3) design and complete
a hypothesis-driven research project; (4) attend interactive research working groups; and (5) participate in the
Department of Pediatrics highly successful grant writing programs. This comprehensive program will train a
new generation of pediatric subspecialty global health scientists equipped to advance the research agenda
outlined in the NICHD Scientific Vision.

Public health relevance
PROJECT NARRATIVE To optimally support child health and development, research needs to be designed to account for the scale of disease burden and child mortality and shifts that occurs worldwide. The Pediatric Subspecialty Global Health Research T32 training program will capitalize on the significant resources that currently exist across the campus of Stanford University to provide dual fellowship training in a pediatric subspecialty combined with research focused on global child health, as well as completion of a Masters in Epidemiology and Clinical Research. This comprehensive program will train a new generation of pediatric subspecialty global health scientists equipped to advance the research agenda outlined in the NICHD Scientific Vision, including studies of the developmental origins of health and disease, pregnancy outcomes, behavior and cognition, and population dynamics at the global level.